PRECHRONIC AND CHRONIC INHALATION STUDY OF OZONE

The objective of this project is to characterize dose-response relationships, toxicity, and carcinogenic potential of ozone administered by inhalation to rats and mice in 28-day repeated-dose and 30 month chronic studies. Animals will be exposed for 6 hours per day, 5 days per week for 28 days or 24 or 30 months. At the end of each study, all animals will be given gross and microscopic histopathologic evaluations. A 20 month interim sacrifice, including histopathology will be performed In the 30 month study. The results of the 28 day study will be used by NTP to establish doses to be used in the 30 month study.